Relevance of mitochondrial calcium uniporter for mitochondrial myopathy

Abstract: This project explores the intersection of two fundamental areas: cellular (mal)adaptation to
primary mitochondrial dysfunction and the biology of the mitochondrial Ca2+ uniporter (MCUC). In humans,
primary mitochondrial disease arises from mutations in nuclear- or mitochondrial-encoded DNA, or from
pharmacological agents or toxins. Skeletal muscle is among the most severely affected organs. Mouse
models of mitochondrial myopathy (MM) show that energy deficit, per se, is not the major factor for
pathology, but, rather, that mitochondrial dysfunction initiate a progression of adaptive and maladaptive
changes in, e.g., metabolism and proteostasis, and also activates endoplasmic reticulum (ER) stress and the
Integrated Stress Response (ISR); the result is muscle atrophy, weakness, and diminished exercise capacity.
Major cytoplasmic signaling pathways beyond the ISR have been investigated but found to not fully explain MM.
Whether processes within mitochondria can impact MM progression has only been narrowly considered.
Published data and our preliminary data document an increased abundance of the MCUC and
increased mitochondrial Ca2+ uptake in MM and myopathies of other origins. The possibility that
mitochondrial Ca2+ uptake contributes to pathology has only been considered in the context of MCUC's ability
to cause a sustained opening of the mitochondrial permeability transition pore (mPTP), which can trigger cell
death. Yet, our preliminary data suggest the hypothesis that the MCUC serves a beneficial role in MM, by
expanding the oxidative phosphorylation capacity of dysfunctional muscle mitochondrial, and blunting the
ISR. This hypothesis will be tested in two Specific Aims, by depletion MCUC in two models of MM (mice
with depletion of PiC in skeletal muscle; mice with whole-body loss of Frataxin), for in vivo and ex vivo
studies. We will also use advanced imaging techniques and genetic sensors to evaluate metabolism,
bioenergetics and redox, and calcium, in a compartmentalized manner, including at the ER-mitochondria
interface, in cells acutely depleted of MCUC. We will also use sophisticated methods to evaluate protein
translation, since this is a key feature of the ISR that can influence muscle mass. Aim 1 will test the hypothesis
that mitochondrial Ca2+ uptake improves energetics during the early phase of mitochondrial dysfunction.
Aim 2 will determine how MCUC contributes to mitochondrial dysfunction-induced ER stress and the ISR
and consequences on cell viability and muscle mass. Aim 3 will test the hypothesis that regulation of MCUC
by MICU3 renders mitochondria vulnerable to sustained mPTP opening such that the MCUC becomes a
liability for skeletal muscle at later phases of mitochondrial dysfunction. These studies are expected to reveal
a novel role for MCUC in the (mal)adaptive response of skeletal muscle to mitochondrial dysfunction and
in regulating muscle mass in myopathy, and, broadly, to provide new insight into the regulation of major
stress signaling pathways that are activated in different myopathies, and many other stress conditions.
.

Public health relevance
Project Narrative This project explores the intersection of two fundamental areas, namely the cellular (mal)adaptation to primary mitochondrial dysfunction and the biology of the mitochondrial Ca2 + uniporter complex (MCUC). Here we propose to test the hypothesis that the MCUC serves a protective role during early stage mitochondrial myopathy, by augmenting energy production and mitigating stress signaling that could lead to muscle atrophy, and a detrimental role during later phases of mitochondrial dysfunction in skeletal muscle. These studies are expected to uncover novel regulation of the (mal)adaptive response to mitochondrial dysfunction and of muscle mass in myopathy, representing new roles for the MCUC in a post- mitotic cell environment.